Glial Cell Regulation of Circadian Behavior

DESCRIPTION (provided by applicant): The human brain contains more than 100 billion cells, the majority being non-excitable glial cells. Recent studies, including those from the applicant's lab, demonstrate that glial cells of vertebrate and invertebrate nervous systems have remarkably dynamic roles in the regulation of physiological and behavioral processes. Studies in mammals have demonstrated that neurons and glia communicate with one another and this has given rise to a model of the tripartite synapse wherein a glial cell (an astrocyte) cooperates with presynaptic and postsynaptic neuronal elements to regulate communication events and behavioral processes (see Significance). Recent studies from the applicant's lab describe a role for a defined population of Drosophila astrocytes in the regulation of circadian behavior. Other studies have documented additional functions for fly glia in the regulation of neurotransmission and behavior (reviewed in Jackson and Haydon, 2008). In the present application, we propose experiments to elucidate the functions of glia in circadian timing. Our studies will employ Drosophila so as to be able to utilize sophisticated genetic techniques to study neuron-glia interactions in the circadian system. The work will utilize innovative genetic, behavioral, imaging and electrophysiological approaches and, importantly, the PI and co-I have complementary strengths in these areas. We propose three specific aims that will test explicit hypotheses about neuron-glia interactions in the circadian system: (1) Test the hypothesis that gliotransmission or other glial processes are essential for circadian behavior; (2) Test the hypothesis that glia regulate pacemaker neurons; and (3) Test the hypothesis that clock neurons regulate glial rhythms. We expect that the results of these studies will highlight general mechanisms by which neurons and glia cooperate to influence circadian rhythmicity and other behaviors. In most neurological disorders and psychiatric states, glial cell gene expression profiles are altered, and it is likely that this initiates dramatic structural/functional changes in the brain that lead to these disorders. Alterations of glial cell biology have been implicated in mental and neurodegenerative diseases including multiple sclerosis (MS), amyotrophic lateral sclerosis (ALS), schizophrenia, epilepsy, and Alzheimer's. Our proposed studies of glia and circadian control mechanisms have considerable significance for an understanding of pathophysiological conditions such as jetlag and sleep/wake disorders resulting from environmental or genetic perturbations of the circadian system. Molecular components of the circadian system are conserved between insects and mammals, including humans, and Drosophila is an outstanding model for conducting genetic investigations of circadian behavior. It is anticipated that the results of our proposed studies will provide important and general insights about the interaction of glia with the neuronal circuitry controlling behavior, insights which are critical for understanding the roles of glial cells in health and disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: The human brain contains more than 100 billion cells, the majority being non-excitable glial cells; we propose studies that will utilize behavioral measures, imaging technology and other neurobiological methods to understand communication between neurons and glia of the adult nervous system. The model we propose to use for understanding neuron-glia communication is the circadian clock system as much is known about the neural circuitry responsible for circadian behavior. Our proposed studies have significance for understanding the roles of glia and neuron-glia communication in health and many different neurological diseases. Project Narrative The human brain contains more than 100 billion cells, the majority being non-excitable glial cells; we propose studies that will utilize behavioral measures, imaging technology and other neurobiological methods to understand communication between neurons and glia of the adult nervous system. The model we propose to use for understanding neuron-glia communication is the circadian clock system as much is known about the neural circuitry responsible for circadian behavior. Our proposed studies have significance for understanding the roles of glia and neuron-glia communication in health and many different neurological diseases. __SpecificAimsTextDelimiter__ Specific Aims This shortened A2 application seeks funds to study the roles of glial cells in behavioral regulation. Glia have well known roles in brain development and as passive support cells, but their dynamic modulatory functions in the differentiated nervous system are less well studied. Recent results, including those from the PI's lab, emphasize the importance of glia for the physiological regulation of neuronal circuitry in mammalian and invertebrate systems [1-8]. This proposal addresses a timely, understudied aspect of behavioral neurobiology: the requirement for glia-neuron communication in the neuronal networks regulating adult behavior. Studies from the PI's lab previously identified a rhythmic glial protein known as ebony - expressed in a subpopulation of Drosophila astrocyte-like glia ("astrocytes") of the central nervous system - that functions in the circadian control of behavioral rhythmicity [7]. Furthermore, we provide preliminary results with this application indicating a physiological role for glial cells in regulating adult circadian behavior. Importantly, recent studies reinforce the idea that astrocytes and astrocyte-neuron interactions are critical for circadian timing in mammals as well [9-13], emphasizing the significance of additional studies in this area. In this proposal, we outline genetic and physiological studies in Drosophila to explicitly test the overarching hypothesis that glia-neuron interactions are essential for adult circadian behavior. Aim 1. Test the hypothesis that gliotransmission or other glial processes are essential for circadian behavior. (1A) Do conditional genetic manipulations of glia alter behavior? Our preliminary studies show that conditional manipulation of Drosophila astrocytes alters circadian behavior. We will continue these studies to determine which aspects of circadian timing require glial functions. In addition, we will examine circadian rhythms in flies with genetic alterations likely to affect Drosophila gliotransmission or other glial cell functions (calcium regulation, membrane potential) to identify processes essential for behavior. (1B) Which glia subtypes are relevant for behavioral rhythms? Distinct neuronal populations control Drosophila morning and evening locomotor activity as well as responses to light and temperature, but whether particular types of glia selectively modulate any of these neuronally-driven activities is unknown. Using transgenic strains developed in two other Drosophila labs, we have shown in preliminary studies that a genetic perturbation of astrocytes but not ensheathing glia results in arrhythmic locomotor activity. In continuing studies, we will selectively manipulate different glial cell subtypes, to identify those that function in different aspects of circadian behavior. Aim 2. Test the hypothesis that glia regulate pacemaker neurons. (2A) Do glial cell deficits alter neuronal clock function? Our preliminary results suggest that adult glia influence the rhythmic activities of circadian pacemaker neurons. We will test this idea further using a multidisciplinary approach to acutely or persistently alter defined glial functions in transgenic flies and examine 1) neuronal clock protein abundance, 2) rhythmic neuronal clock gene transcription, and 3) clock neuron excitability using electrophysiology or Ca2+ reporters. To test the idea that glial Ca2+ stores are important for glia-neuron communication, as suggested for mammals, an additional study will selectively perturb glial Ca2+ signaling and examine clock neuron activities. (2B) Test the hypothesis that glial clocks influence clock protein cycling in neurons. In response to reviewer comments, we have added this subaim to test the hypothesis that glial molecular rhythms are essential for neuronal clock activities. We will selectively alter glial clock protein rhythms, using genetic methods, to determine whether glial clocks are important for neuronal clock protein cycling and behavior. Aim 3. Test the hypothesis that clock neurons regulate glial rhythms. In Drosophila and mammals, clock gene expression and clock protein rhythms have been documented in glial cells [12, 14], although the biological significance of such rhythms is unknown. Similarly, a recent study indicates that extracellular ATP - which is converted to the 'gliotransmitter' adenosine - exhibits circadian fluctuations in abundance in the Suprachiasmatic nuclei (SCN, the mammalian pacemaker) and in cultured astrocytes [9]. Studies also suggest that release of Vasoactive Intestinal Polypeptide (VIP) from SCN neurons may regulate mammalian glial rhythms [11]. However, neuron-dependent regulation of glial rhythms has not been adequately explored, in vivo, in any system. We will test whether neuronal circadian pacemaker output is essential for glial rhythms by genetically altering clock neurons, in vivo, while monitoring glial cell molecular rhythms. As requested by reviewers, we will also selectively rescue clock function in neurons or glia, in a clock mutant background, to ask if neuronal output is required for glial cell molecular rhythms (Ebony or clock protein rhythms). These studies will make use of existing transgenic strains permitting cell type-specific genetic manipulations of subpopulations of fly clock neurons to define those relevant for glial rhythmicity. The proposed experiments will employ multidisciplinary genetic, imaging, electrophysiological and behavioral approaches to determine the importance of glia-neuron interactions in the circadian circuitry. Such studies have great significance for understanding sleep and psychiatric disorders resulting from impaired circadian function. Importantly, the studies may also identify novel glial cell targets relevant for the treatment of such disorders.